The molecular mechanisms of mitochondrial behavior.

Project Summary/Abstract: Mitochondrial fusion regulates the shape, distribution and function of the organelle and plays critical roles in protection from cell death and therefore offers a valid target for theurapeutic approaches to protect the heart from progression of disease or myocardial infarction events. Mitochondrial fusion is mediated by members of the dynamin related protein (DRP) family, large GTPases that, through their ability to self-assemble and hydrolyze GTP, control membrane remodeling events. In mammals, MFN1 and MFN2 function in place of a single outer membrane DRP in simple organisms, both are expressed ubiquitously but the relative expression level of each varies in a tissue dependent manner. Although MFN1 and MFN2 both function in mitochondrial fusion, they are not completely redundant, although the nature of the functional differences are not known. Our data indicate that the MFN1-MFN2 heterotypic trans complex is significantly more efficacious for fusion than either homotypic complex. From this, we predict that MFN1 and MFN2 have distinct molecular properties and that the functional significance of the two outer membrane DRPs in mammals is to provide a relatively simple regulatory fusion mechanism via their respective and relative expression levels. Further, data suggest that specific regulatory mechanisms exist, as we have shown that soluble Bax stimulates only MFN2 homotypic complexes. In order to understand the functional significance of two outer membrane fusion proteins and the regulatory mechanisms that govern their activity, we propose to characterize the biochemical properties of each DRP including GTP binding, GTP hydrolysis and complex assembly. These biochemical approaches together will determine the mechanistic basis for why MFN1 only, MFN2 only and MFN1/MFN2 mediated fusion efficiencies are distinct and will likely point to why and how they are distinctly regulated in cells. To explore what properties of MFN2 are modulated by the pro-apoptotic Bcl2 protein Bax, we will test the effect of Bax on the biochemical properties of MFN2, of particular significance in the heart where MFN2 is the predominantly expressed fusion DRP. We will further characterize the regulation of fusion by Bax through identification of interaction domains and exploring their functional significance in vitro and in cells. Bax also negatively effects mitochondrial fusion following activation by apoptotic signals and we will investigate whether the inhibition of fusion is direct or mediated through outer membrane permeabilization. As observed with the apoptotic pathway and mitochondrial dynamics, an interdependence also exists between mitochondrial fusion and mitochondrial motility, but the significance of this is relatively unexplored. We propose that mitochondrial tethering to microtubules and short range motility are both important regulators of mitochondrial fusion. We will determine the role that mitochondrial movement and tethering play in regulating mitochondrial fusion and investigate the molecular basis for the requirement of MFNs in these processes using an in vitro mitochondrial fusion-motility assay and complimentary biochemical approaches.

Public health relevance
Project Narrative The experiments proposed in this grant will shed light on the fundamental mechanism of mitochondrial fusion, providing a foundation to further understand the physiological roles this process plays in cardiac function, under all circumstances including the healthy heart, in chronic heart disease and during myocardial infarction events. By probing the mechanistic link between mitochondrial fusion and apoptosis and the interdependence of mitochondrial fusion and mitochondrial tethering and motility, we will gain insight into the regulatory mechanisms that exist in cells. These approaches will contribute to the identification of novel targets for drug development and therapeutics for heart disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Mitochondrial fusion regulates the shape, distribution and function of the organelle and plays critical roles in cell physiology as evidenced by the fact that deletion and mutations of mitochondrial fusion genes result in embryonic lethality, neurodegenerative diseases and stroke1. Mitochondrial fusion is highly regulated and integrated into cellular signaling pathways. Specifically, mitochondrial fusion proteins play distinct regulatory roles in Bcl2 protein mediated apoptosis and conversely, in healthy cells Bcl2 proteins regulate mitochondrial fusion. Evidence also suggests that mitochondrial fusion proteins function separately to regulate and integrate mitochondrial motility with fusion. Two classes of highly conserved integral dynamin-related proteins (DRPs) mediate mitochondrial outer and inner membrane fusion: Mfn1/2 and OPA1, respectively. I developed an in vitro mammalian mitochondrial fusion assay to assess the relative roles of MFN1 and MFN2, which function in place of a single protein in simpler organisms. Data indicate that the MFN1- MFN2 heterotypic trans complex is significantly more efficacious for fusion than either homotypic complex. From this, we predict that MFN1 and MFN2 have distinct molecular properties and that the functional significance of the two outer membrane DRPs is to provide a relatively simple regulatory fusion mechanism via their respective and relative expression levels. I have also used the in vitro assay to probe the basis for the regulation of fusion in cells and demonstrate that the soluble form of the pro-apoptotic Bcl2 protein Bax only increases MFN2 homotypic trans complex-dependent fusion, indicating that unique regulatory mechanisms exist for each fusion complex. The molecular basis for the functional and Bcl2-dependent regulatory distinctions between MFN1 and MFN2 is not understood. Furthermore, although we know that an intimate link exists between mitochondrial motility/tethering and MFN-dependent fusion, the nature of this link has not yet been explored. To address these deficits I will: 1. Characterize the biochemical properties of MFN1 and MFN2. I hypothesize that the functional distinctions between MFN1 and MFN2 is a result of unique DRP activities, such as complex assembly or GTPase activity. I will characterize the structural and biochemical properties of purified MFN1 and MFN2 and translate the biochemical observations to the in vitro fusion assay and to cells in culture to determine their significance. 2. Determine the mechanistic basis of the regulation of mitochondrial fusion by Bcl2 family protein Bax. We will explore the molecular basis for MFN2-specific regulation of fusion by Bax by mapping interaction domains and exploring their functional significance in vitro and in cells. We will explore the modulation of the biochemical characteristics of MFN2 by Bax in conjunction with Aim 1. In addition, we will determine if apoptotic active Bax directly inhibits mitochondrial fusion using chemical and genetic approaches. 3. Investigate the relationship between mitochondrial motility/tethering and mitochondrial fusion. Time-lapse analysis of mitochondrial fusion in cells indicates that mitochondrial movement and mitochondrial fusion are interdependent. I have recapitulated motility dependent mitochondrial fusion in vitro and demonstrate that it is reciprocally dependent on MFN1 and MFN2. Using my in vitro coupled mitochondrial motility/fusion assay and additional complimentary approaches, I will determine the role that mitochondrial movement and tethering play in regulating mitochondrial fusion and investigate the molecular basis for the requirement of MFNs in these processes. This approach will provide fundamental insight into the mechanism of mitochondrial fusion and its regulation. Given that MFN2 is predominantly expressed in the heart, the knowledge gained will be directly relevant to development of therapeutics for treatment of heart disease as the experiments address the basis of Bcl- regulated mitochondrial fusion via MFN2 homotypic complexes. Approaching mitochondrial motility/tethering as a regulator of mitochondrial fusion will identify novel targets for drug development and therapeutics for heart disease.